What triggers RV Fiber Re-Orientation in response to RV pressure overload, and what is its Consequence on Inter-Ventricular Decoupling?

PROJECT SUMMARY
Pulmonary hypertension (PH) is a cardiopulmonary disease that ultimately leads to right
ventricular (RV) failure. Currently there are no approved therapies targeting the RV and most
research is focused on reducing fibrosis, although it is unclear if this will ultimately improve RV
pumping function. However, the orientation of collagen and cardiomyocyte fibers likely have a
major influence on RV function and are largely overlooked in ongoing research and clinical
practice. Furthermore, the role of the left ventricle (LV) in RV function is almost completely
discounted, but previous research from the 90’s has suggested that the LV is more important for
RV function than the contracting RV free wall.
Our preliminary data shows that LV torsion rate is reduced in children with PH and in
mice after pulmonary arterial banding (PAB), which is correlated with reduced RV ejection
fraction in both species. However, when we induced LV pressure overload in the PAB mice (by
partial aortic constriction), we improved their LV torsion rate and RV systolic function. This was
further validated with in silico studies of the bi-ventricular heart, which showed that targeting LV
torsion rate could improve RV systolic function, but it depends on RV free wall fiber orientation.
Therefore, these results left us with the following questions: (1) What new orientation do the
fibers adopt in response to pressure overload (our preliminary results are not consistent with
others), and does this new orientation improve or worsen RV function? (2) How does RV fiber
re-orientation impact LV-to-RV mechanical assistance during systole? (3) How does the
transient fiber re-orientation and stiffening impact mechanical stress/strain within the tissue, and
how does that impact -or is driven by- gene expression?
In this study, we will combine the PAB mouse model with in silico simulations to
investigate how changes in RV fiber orientation and stiffening, in the RV free wall, impact RV
pumping function. Then, we will combine PAB with aortic constriction to study how RV
remodeling interferes with LV torsion and if this interrupts LV-to-RV mechanical assistance
during systole. Finally, by collecting a time course dataset of imaging and gene expression, we
will identify genes that are directly impacted by changes in mechanical stress and expose how
they trigger their downstream remodeling pathways.
The questions being answered in this project will lead to a better understanding of how
RV structural remodeling, in response to pressure overload, impacts RV function and
interventricular coupling, and identify target genes governing this process for future studies.

Public health relevance
PROJECT NARRATIVE Pulmonary hypertension (PH) is a progressive disease with a high mortality rate due to ultimate right ventricular (RV) dysfunction and failure. The overall hypothesis of this project is that a cascade of RV fiber re-orientation and changes in LV contractile mechanics are potential targets to halt or reverse functional decline, which have not been explored. The successful completion of this project would confirm that these are targets worth pursuing and reveal the potential transcriptional and structural changes that could be exploited.